EVALUATION AND TREATMENT OF CHILDREN WITH FETAL ALCOHOL SYNDROME

The purpose of this project is to determine the efficacy treatment with methylphenidate on attention deficits and hyperactivity in the Fetal Alcohol Syndrome/Fetal Alcohol Effects population.